The Neurospan Bridge: A Device for Peripheral Nerve Repair

Peripheral Nerve Injury (PNI) occurs in 3% of all trauma cases and 30% of combat injuries to
the extremities, resulting in a loss of five million working days each year and costs of $150
billion annually in the U.S. The standard of care in the clinic is a nerve autograft from the
patients’ leg. The NeuroSpan Bridge is a unique, biomimetic, multi-channel scaffold that
maintains linearity throughout the structure, thus accelerating and guiding regenerating axons
precisely to their targets on the distal end of the transected nerve. It has been extensively tested
in gaps up to 3cm-long and demonstrated superiority to existing devices in a short-gap animal
model, and superiority to nerve autograft in a long-gap animal model. This project will put in
place a program to finalize pre-clinical studies, submit an IDE application to the FDA and carry
out a feasibility clinical study followed by 510(k) application. The proposed project brings
together experts in peripheral nerve injury, axonal regeneration, neurology, neurosurgery and
bioengineering to develop a practical, cost-effective, consistent, and transnationally relevant
medical device for the treatment of peripheral nerve injury.

Public health relevance
Peripheral nerve gap injuries occur in 3% of all trauma cases and 30% of combat injuries to the extremities, resulting in a loss of five million working days each year and direct medical costs of $150 billion annually. Auxilium Biotechnologies Inc. proposes to develop for human use the NeuroSpan Bridge, a biomimetic, multi-channel scaffold that exhibits bioequivalency or superiority to human sural nerve autografts to support functional regeneration after injuries over gap lengths up to 3 centimeters.